Effect of aging and senescent cells

Project Summary
The goal of this proposal is to understand how aging and senescent cells impact resident memory T cell
differentiation, longevity, and functional interactions with individual tissue cell types, including parenchymal,
stromal, innate and adaptive immune cells. Single cell assays will address gaps in understanding of resident
memory T cell dialogue with resident hematopoietic and non-hematopoietic cells in both mouse and humans.
The impact of the age of the organism, the age of the T cell, or targeted elimination of senescent cell populations
will be tested as isolated variables. This study will inform mechanisms of immune disfunction in the elderly and
therapeutic opportunities for rejuvenating tissue immunity.